Biodefense & Infectious Diseases Short-Term Training to Increase Diversity in Biomedical Research

ABSTRACT
The goal of the Summer Medical Research Internship (SMRI) is to exploit the rich research community at
the University of Virginia (UVA) to expose medical students to the excitement, capabilities, rigors, and
breadth of opportunities for careers in allergy and infectious diseases research. From its inception, the
major goals of this NIAID-supported program have been to: (1) provide a high-quality, immersive, hands-
on research experience in allergy or infectious diseases, igniting the passion of the next generation of
physician-scientists; (2) introduce trainees to the rich synergy between basic research and clinical care;
(3) instruct trainees on how to communicate about scientific discovery to audiences with different
backgrounds and levels of expertise; and 4) inform trainees about different approaches through which
research can be successfully incorporated into a career in clinical medicine, with an overarching goal of
kindling and nurturing a passion for doing research that truly makes a difference and leaves a mark on
mankind. This application seeks support to continue this successful program, through which ten (10)
medical students will be supported each year. The ten-week program has three educational components.
The first and most important is an immersive, hand-on research experience mentored by of one of our 52
program faculty and focused in the mission areas of the NIAID. Second, the trainees participate in a
weekly 1-hour workshop focused on developing and refining written and oral scientific communication
skills appropriate for various contexts and audiences. Finally, the trainees attend a weekly professional
development luncheon series. One part of this series, titled “Conversations with a Physician-Scientist,”
features faculty who have each taken a different approach to incorporating research into their career in
clinical medicine. The second part is a seminar series which features highly successful researchers from
across the UVA community, who present their research and discuss their career path. Through strong
mentorship, hands-on research, innovative educational initiatives, and exposure to a wide range of
perspectives on combining research and clinical interests, trainees in the SMRI are uniquely prepared to
pursue advanced training with the ultimate goal of becoming members of the physician-scientist workforce.
!

Public health relevance
NARRATIVE The landscape of biomedical research in the United States is changing, as are the composition and activities of the biomedical research workforce. With this evolution comes an increasing need to encourage talented medical students to pursue careers that will contribute to a better understanding of the factors that promote the diseases under investigation, the development of methodologies to predict and/or prevent disease progression, and the discovery of therapies that will help cure patients. The Summer Medical Research Internship (SMRI) at the University of Virginia addresses this need by providing medical student trainees with an immersive research experience within a rich allergy and infectious diseases research community that boasts strong and diverse basic science and opportunities for exposure to the practice and challenges of providing clinical care to patients. The overall goal of the SMRI is to provide our summer trainees with the knowledge, tools and motivation to consider how they might contribute to the discoveries of the future as physician-scientists and/or members of collaborative research teams.